Improving Officer and Civilian Health through Macro-level Changes in North Texas

1.- Modified Project Summary/Abstract Section

Title: Improving Officer and Civilian Health through Macro-level Changes in North Texas

As a profession, law enforcement produces unique occupational health outcomes for officers and civilians. To date, most studies have focused on improving health outcomes related to law enforcement from a microlevel perspective, with particular attention to individual and behavioral factors. Such a focus misses the broader macro-level factors that perpetuate occupational harms. To address this gap, this study uses the PRECEDE-PROCEED model of intervention development to examine modifiable macro-level factors contributing to adverse occupational health outcomes for law enforcement and civilians. Using a mixed-method design and partnering with local law enforcement agencies, we will implement and test an intervention to reduce occupational health harms related to law enforcement.

Public health relevance
3. Modified Public Health Relevance Section This solutions-oriented intervention study focuses on reducing harms associated with law enforcement as a hazardous occupation for 1) officers and 2) populations with elevated rates of experiencing use of force and arrest. By reducing administrative and operational burdens, this study aims to assess interventions that may reduce officers’ exposure to injurious events. Collectively, this project will assess activities intended to protect officers’ health and well-being in a high-risk occupation while also positively affecting civilians’ outcomes.